Studying the role of eIF4A in Pancreatic Cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) remains largely incurable and recent studies have shown that the
metabolic pathways of PDA cells are profoundly rewired. Nonetheless, this metabolic rewiring may also
engender liabilities that can be exploited for PDA treatment. Using genetically-engineered mouse models and
pancreatic ductal organoids, we previously showed that PDA cells are dependent upon KRAS-mediated
increases in protein synthesis. As several key oncogenic signaling pathways converge on the eukaryotic
translation initiation factor 4F (eIF4F), we recently examined whether an inhibitor (CR-31) of its associated RNA
helicase (eIF4A) affects the viability of PDA cells. Strikingly, CR-31 impaired the translation of mRNAs encoding
enzymes involved in various metabolic pathways selectively in cells of PDA, but not normal, ductal organoids.
Moreover, while gemcitabine, the only existing monotherapy for PDA, does not extend the survival of PDA-
bearing mice, we observed that CR-31 alone suppressed PDA tumor growth in vivo. Thus, we hypothesize that
eIF4A is a key regulator of pancreatic cancer translation with unique potential as a therapeutic target against
PDA. To realize the potential of eIF4A inhibition in the clinical setting, we propose to define the mechanism of
eIF4A-dependent transcript-specific translation in pancreatic cancer cells (Aim 1), determine the translational
targets of eIF4A that promote PDA (Aim 2), and identify adaptations induced by eIF4A inhibition that can be co-
targeted to more effectively treat this lethal malignancy (Aim 3). This project builds on our expertise in PDA
biology, organoid culture, RNA genomic analysis, as well as access to patient-derived specimens to evaluate
clinical relevance. In addition to illuminating basic mechanisms, the proposed studies will test several novel
treatment options for PDA.

Public health relevance
PROJECT NARRATIVE The current proposal “Studying the role of eIF4A in pancreatic tumorigenesis” will use organoid models, RNA genomics, and biochemical tools to realize the potential of eIF4A as a therapeutic target against pancreatic cancer. We anticipate our results will establish mechanistic understanding and therapeutic inroads for translation reprogramming in pancreatic cancer.